Deciphering The Evolutionary and Biological Impact of Human Admixture

Project Summary
Admixture is a vital evolutionary process that profoundly shapes human genetic diversity and health.
Current evidence suggests that admixture is ubiquitous throughout human evolution and has been
accelerating during our recent evolutionary history. However, despite the paramount importance of
admixture, we still lack sufficient means to infer a complete admixture history in humans. Due to the
underrepresentation of non-European populations in biobanks, we also do not fully understand the
genetic basis of complex traits in admixed populations. Furthermore, constrained by our long
generation time, we do not have a holistic view of how admixture interacted with other evolutionary
processes such as selection, and how they shaped genomes over time. Synthesizing computational
methods development and empirical population genomics, my lab will decipher the evolutionary history
and biological impact of human admixture via three lines of work. First, we will develop machine learning
methods to investigate some of the oldest admixture events, the archaic introgression, in understudied
non-European populations. Specifically, we will search for evidence of introgression with unknown,
“ghost” hominins in East Asians, and leverage the evolutionary trajectory of adaptive introgression gene
regions to infer a comprehensive population history for South Americans. Next, we will focus on the
impact of recent admixture in shaping complex traits in modern humans. We will use simulations to
model changes in the underlying genetic architecture of complex traits caused by admixture and
develop novel statistical methods to improve the accuracy of complex trait phenotype predictions in
populations that experienced recent and ongoing admixture. Finally, we aim to elucidate the real-time
process and functional consequences of admixture using two nonhuman study systems with shorter
generations. We will use interbreeding Drosophila species to experimentally track the dynamics
between admixture and selection on admixed genomes over time. We will couple the work with an
admixed captive colony of rhesus macaques that has longitudinal records of genomic and phenotypic
data to investigate how admixture changes individual fitness and phenotypes directly relevant to
humans. Overall, this research will provide invaluable empirical evidence and powerful quantitative
tools to enhance our understanding of human admixture from complementary perspectives.

Public health relevance
Project Narrative By exchanging genetic variants between populations, admixture has profoundly shaped human population history, courses of natural selection, and phenotypes and disease burdens across populations. Failure to consider admixture or the use of wrong models can lead to major adverse consequences in biomedical applications. This research combines analytical, computational, and experimental approaches, and will generate novel insight into the evolutionary and functional consequences of admixture, improve our knowledge of complex traits etiology, and inform strategies to help reduce health disparity in admixed, underserved populations.